Center for Targeted Therapeutics

ABSTRACT
The principal Phase II goal of the COBRE Center for Targeted Therapeutics (CTT) is to conduct vital research
oriented at identifying novel drug targets and discovering new targeted drugs, while enhancing the career
development and research competitiveness of Center investigators. Targeted therapeutics is a broad term for
research that seeks to develop new and more effective classes of drugs against various diseases, by selectively
aiming these drugs at molecular and cellular targets that play a key role in the disease. The area of Targeted
Therapeutics has been chosen because of its societal impact, the emergence of common technologies driving
therapeutics research in different disease areas, and the presence of a critical core of senior faculty with broad
acumen and trans-disciplinary vision in Targeted Therapeutics at USC. During Phase I, junior investigators
leading CTT research projects (target PIs) were awarded five R01s and several smaller grants, and pilot project
recipients received two R01s and several other grants, for a total of close to $14 million. Four target PIs received
promotion and tenure and almost 50 published papers acknowledged COBRE support. Three resource cores
established by the CTT provided services to 64 different laboratories and organized training workshops and a
new graduate course. To build upon the success of Phase I, we will pursue the following Specific Aims.
Aim 1. Support high-impact research projects and assist junior scientists in Targeted Therapeutics in their
professional development and competitiveness for NIH grants, in a collaborative and nurturing environment.
Target junior faculty members include four highly promising scientists, each of whom will be mentored by two
senior scientists with different areas of expertise relevant to their research.
Aim 2. Establish sustainable research infrastructure through the further development of strategic Cores for
Targeted Therapeutics research. The Center supports research cores in Functional Genomics, Drug Design and
Synthesis, and Microscopy and Flow Cytometry. These cores will provide both specialized services and
intellectual scientific support.
Aim 3. Assure long-term development of the CTT by broadening collaborative networking, fostering continuous
recruitment, supporting new faculty in Targeted Therapeutics, and supporting pilot research projects, with an
emphasis on drug discovery and preparation for multi-investigator and SBIR/STTR grant applications. CTT will
conduct regular meetings and seminars and promote external collaborations. CTT will participate in the
recruitment of five new junior faculty members to USC and will continue working with the “graduated” target
faculty, assuring that they continue to make important discoveries and win grants. Continued success of the CTT
will make an impact on the public health, scientific education and economic development of the State.

Public health relevance
NARRATIVE The Center for Targeted Therapeutics (CTT) brings together junior and senior faculty with a common interest in the discovery of new molecular targets and prototype drugs for the treatment of common and serious diseases. Within the CTT junior faculty are mentored by established investigators who are experts in their respective fields. CTT faculty members work together to promote the rapid advancement of their field, and to train the next generations of scientists and mentors.